Cell tracking in low-frame-rate video based on displacement prediction

Project Summary
Tracking living cells in video sequences is a fundamental task in many fields of science,
including biochemistry, bioinformatics, cell biology, and genetics. Manually linking cells is
extremely time-consuming and not feasible in large-scale analysis. Automatic approaches can
compute cell links by measuring how close two instances of a cell are, or how similar they look.
These techniques work well with video acquired at a relatively high frame rate, but,
unfortunately, acquiring images at high frame rates affects cells negatively. Too frequent
imaging not only causes phototoxicity, leading to experimental artifacts, but also
photobleaching, leading to the inability to measure quantities of interest over time. In addition,
during image acquisition, the environment temperature and air quality are typically less
controlled, which could also contribute to cytotoxicity. Moreover, when performing high-
throughput live-cell imaging, the lower the acquisition rate, the more cells/plates can be imaged,
and, consequently, the more experimental treatments can be applied and studied.
If reducing the acquisition rate is beneficial for all these reasons, it severely affects the accuracy
of cell tracking algorithms. To this end, we propose a new class of cell tracking approaches based
on cell movement predictions. Instead of comparing cells based on their similarity, we propose
to predict where every cell will move in the next frame. This will allow for searching the
occurrence of such cells, even if the next frame was acquired after an extended period. The
new approach will be investigated using a newly generated dataset for low frame rate cell
tracking (Aim 1). Cell displacement will be predicted by using a new Recurrent Neural Network
designed for the task (Aim 2). Cell tracking algorithms will be defined re-evaluating existing
approaches under low-frame rate constraints when using cell displacement information (Aim
3).
While current approaches require image acquisition to occur at least every 5-15 minutes, we
will investigate the feasibility of cell tracking on images acquired at intervals of up to 2 hours. If
successful, our research will allow to accurately track cells in low frame rate video sequences
without the need for specialized tools or equipment.

Public health relevance
Project Narrative Allowing the use of low frame rate videos for cell tracking will enable researchers to study cell dynamics at scale, multiplying the number of experimental treatments tracked concurrently, and reducing the number of experimental artifacts generated. This proposal focuses on cell displacement prediction to overcome the limitations of current cell tracking approaches. Given the importance of studying cell dynamics, the results of our research will have very broad applicability in many areas of biomedical science, including developmental biology, drug discovery, and regenerative medicine.